POSTMENOPAUSAL ESTROGEN/PROGESTIN INTERVENTION TRIAL

Double blind, placebo controlled, multi-center trial of the effect of estrogen and estrogen/progesterone on high density lipoprotein, cholesterol, plasma fibrinogen and plasma insulin levels.